The role of capsule production on the physiology of an oral commensal

Abstract
The hydrogen peroxide (H2O2)-producing oral commensal, Streptococcus parasanguinis, plays a major role in
maintaining oral homeostasis in a nitrite (NO2)-dependent manner. Specifically, salivary NO2 produced by nitrate-
reducing bacteria reacts with H2O2 to produce reactive nitrogen species (RNS), such as peroxynitrite (ONOO-),
which is an antimicrobial that targets diverse pathogens, such as Streptococcus mutans, Enterococcus faecalis,
and Aggregatibacter actinomycetemcomitans. In S. parasanguinis the production of H2O2 is mediated by the
poxL (pyruvate oxidase) gene, which is homologous to the Streptococcus pneumoniae spxB gene. Multiple
studies have shown that in S. pneumoniae H2O2 production has an inverse relationship with capsule production.
Capsule production in S. pneumoniae is important for biofilm formation and oxidative stress resistance. However,
the relationship between capsule production and H2O2 production, oxidative stress tolerance, and biofilm
development remains unknown in S. parasanguinis. Additionally, the role of capsule in NO2-mediated nitrosative
stress tolerance remains unstudied. S. parasanguinis harbors a capsule biosynthesis (CPS) operon that is
homologous to the S. pneumoniae CPS operon, indicating that the roles of capsule may function in a similar
manner to S. pneumoniae as it pertains to fitness. CpsE, a galactosyl transferase, is required for initiating the
addition of the first monosaccharide in the formation of S. parasanguinis polysaccharide capsule biosynthesis.
The goal of this project is to characterize the role of S. parasanguinis CpsE in modulating H2O2 production, NO2-
mediated stress tolerance and biofilm formation, and commensal fitness within multispecies biofilms. We
hypothesize that capsule production plays a critically important role in S. parasanguinis biofilm formation, stress
response, and polymicrobial interactions. The specific aims of this project are to: 1) Determine the role of capsule
production on S. parasanguinis biofilm development and stress tolerance, and 2) Determine the role of capsule
production on S. parasanguinis’ microbial competition. Ultimately, the completion of the proposed aims will
provide new knowledge about the role of capsule in oral commensal fitness, colonization, and ability to
antagonize oral pathogens, which has never been studied.

Public health relevance
Project Narrative Microbial-induced oral diseases are the leading cause of infectious diseases world-wide. Oral commensal streptococci are primary mediators of health and homeostasis in the oral cavity. Hence, it is critically important to understand the molecular mechanisms that govern their fitness and ability to antagonize oral pathogens.